Supplement request for Cellular mechanotransduction - from the immune response to transcriptional regulation

Cell-cell and cell-substrate interactions, mediated by adhesion and signaling receptors, are highly dynamic and
subject to cytoskeletal movements that impart substantial mechanical force at the interface. How cells combine
mechanical and biochemical signals to carry out specific functions is not well understood. Supported by this
MIRA award, we are examining how mechanical cues are relayed to the nucleus to regulate gene expression
in a functionally appropriate manner and how mechanical cues interact with tissue-specific cues. This requires
an imaging system capable of multicolor single-molecule imaging with high signal to noise ratio deep within the
cell nucleus. Highly Inclined Laminated Optical Sheet (HILO) Microscopy is an imaging technology that allows
for visualization of single molecules deep within the cell interior with nanometer scale resolution. Single
molecule imaging of transcription factor mobility and binding yields a dynamic view of gene regulation at the
single cell level, thus complementing high throughput genomic studies. In preliminary studies, we have shown
that transcription factors and histones exhibit multiple low mobility states, indicative of a complex interaction
between the heterogeneous dynamics of chromatin and TF binding to these chromatin mobility modes. In order
to study how cells integrate mechanical and chemical cues, we are using hydrogels of tunable stiffness to
examine the regulation of transcription by mechanical cues. While conventional Total Internal Reflection
Fluorescence (TIRF) capable microscopes can be adapted to HILO imaging of cells on glass coverslips,
imaging cells on hydrogels (30-50 micron thickness) poses a challenge due to the thickness and the excess
scattering of light within the intervening gel. Furthermore, the relatively low power lasers within our setup limits
the signal to noise ratios necessary for tracking single molecules at fast imaging rates, making the analysis of
TF diffusion and chromatin dynamics at sub-second timescales difficult. This supplement request is to upgrade
the HILO microscopy capabilities of our current TIRF microscope by adding an advanced azimuthal TIRF
module, higher power lasers and pixel-registered multicolor single molecule imaging modules. As single
molecule imaging is directly related to all of our original Aims, this enhanced capability will inform all our
proposed studies. Moreover, the high speed imaging capability will enable us to apply our newly developed
algorithms to study transcription factor mobility and chromatin interactions. Our studies of mechanosensing
and the regulation of transcription by mechanical properties of the cellular microenvironment and the
underlying pathways will advance our understanding of breast and other cancers.

Public health relevance
Changes in the mechanical properties of tissues are reliable markers of disease – for example tissue density is one of the strongest risk factors in cancer progression, while immune cells exploit mechanical signals to kill cancer cells. How mechanical cues regulate cell function remains poorly understood. We are requesting an equipment supplement to upgrade our current microscope to augment our capabilities for multi-color single molecule imaging to study how transcription factor dynamics is regulated by the mechanical properties of the microenvironment.